Community Engagement and Training Core

COMMUNITY ENGAGEMENT AND TRAINING CORE
Project Summary/Abstract
Mississippi is among the most medically underserved states in the nation and infamous for the poorest health
outcomes. In states like Mississippi, the research workforce is limited by a lack of mentorship and training
opportunities to conduct health research among underserved communities. The Community Engagement
and Training Core (CETC) will leverage previously built community infrastructure to engage faculty, students,
and the public in community-based participatory research (CBPR). It will enable collection of complex
community data to answer critical biomedical and behavioral questions that will lead to actionable information
that will translate discovery to practice through intervention research, clinical trials, and health innovations. The
long-term goal is to improve the health of Mississippians by increasing representation of Mississippi
communities in research through workforce development of scientists and health professionals. The CETC will
foster opportunities for transparent and positive research interactions between academics and lay
communities, increase the representation of Community-Based Organizations (CBOs) and city and state
entities in research. The CETC will achieve this long term goals through the following specific aims: 1) Support
pilot projects in CBPR through engaging CBOs with an emphasis on preventable conditions that influence chronic
and infectious disease prevalence that disproportionately affect minorities, rural populations, and other medically
underserved groups in Mississippi; 2) Augment biomedical and behavioral research projects at Primarily
Undergraduate Institutes (PUIs) as well as other academic researchers with CETC infrastructure and
community engagement initiatives to enhance communication between scientists and medically underserved
groups; 3) Develop the next generation of scientists and practitioners through an intensive summer research
program that emphasizes integrated, community participatory approaches to implement science in service of
addressing health disparities in Mississippi. At the completion of the next award period, the CETC will have
greatly increased the number of students, faculty and organizations involved in CBPR, furthering Mississippi's
biomedical and behavioral research infrastructure to improve the health of underserved Mississippi
communities.

Public health relevance
Project Narrative: The Mississippi INBRE Community Engagement and Training Core will provide essential outreach services to enable community-based participatory research projects with academics and community organizations. It also offers a state-of-the-art summer program to promote students into community health- related careers. This will be accomplished by 1) supporting community-based organizations in collaboration with the Mississippi Center for Clinical and Translational Research, 2) Support the community-based participatory research and outreach needs of academics, and 3) administer a summer program in the area of community health research.